Preoperative Risk Prediction of Postoperative Complications for Elective Cardiac Surgery using At-home Smartphone Dynamometry

Project Summary/Abstract
Surgical complication represents one of the biggest factors impacting quality of care and is one of the major
burdens on the healthcare system. There are 40-50 million surgical procedures performed in the US annually
with a mortality rate of 1.3% (650,000 people) and morbidity rate of ~14% (7M people). The mortality rates
significantly increase for patients who are frail, with a heightened risk of 5.1%, and continues to increase into 90
and 180 days for those who are deemed very frail, reaching a staggering 43%. The difficulty in increasing surgical
success is not necessarily in improving the surgical procedures, but rather the perioperative care that surrounds
the surgery: pre-habilitating the patient into fitness prior to surgery, improving patient recovery to discharge
patients to recover comfortably at-home, detecting onsets of complications early to provide non-emergent
treatment. The main objective of this project is to develop a hand grip strength (HGS) measurement solution
based completely on a smartphone application that converts the phone’s vibration motor and sensor into a mobile
dynamometer. Our scientific premise, demonstrated by a berth of clinical evidence, is that hand grip strength
provides a biomarker of physical frailty that corresponds to general physiologic reserve and cardiopulmonary
status, as well as systemic inflammation. Prior studies have linked a diminutive HGS preoperatively to
heightened risk of surgical complications. This corresponds well to evidence that frailty, which correlates strongly
to a weakened HGS, is a major risk factor for surgical complications due to the extremely taxing nature of surgical
procedures on the body requiring a level of fitness to recover after the operation. Although HGS as a measure
is possible with commercial HGS dynamometers, a smartphone-sensor enabled digital dynamometer can make
measurements guided through adaptive interface, automatically digitized, and integrated with ML analytics. With
the patient’s own smartphone, progress of pre-habilitation can be assessed to determine fitness to undergo
surgery, changes in health status can be detected, and timely changes in surgical plan can be made. To increase
the scalability of HGS screening, we propose a smartphone assessment that patients, including older adults, can
administer themselves at home that tracks changes in HGS during the preoperative period. We will further
develop and evaluate different machine learning algorithms that use the HGS feature biomarkers measured by
the phone to perform automated risk prediction of postsurgical outcomes. Because the project would be carried
out in the rich research context of UC San Diego Division of Perioperative Informatics in the School of Medicine
in conjunction with the Anesthesiology Preparedness Clinic, it will be possible to validate the mobile
dynamometer assessments with a cohort of surgical patients undergoing medium to high-risk procedures that
would benefit most from a stratified risk assessment protocol. Our translational goal is to provide access to low-
cost, digital at-home HGS monitoring to transform the way perioperative care is conducted, from one that is
sparse and poorly assessed, to one that is highly integrated through close monitoring and feedback.

Public health relevance
Project Narrative Recent research has shown that hand grip strength (HGS), an index linked to systemic physiological frailty and all-cause mortality, may provide a new biomarker of risk assessment of surgical readiness and potential of postoperative complication; diminutive preoperative HGS indicates a heightened risk of postsurgical complication. This project aims to develop a self-administrable dynamometer for older adults that uses a smartphone’s built-in vibration motor and sensor to record HGS, with the goal of enabling a machine learning- based risk prediction prior to admission day-of-surgery. An automated phone-sensor based surgical outcomes prediction tool has the power to enable remote monitoring to guide preoperative care through adapting prehabilitation protocol and timely intervention for unexpected health status changes needed for maximizing surgical preparedness.